U-RISE at California State University San Bernardino

Abstract
The mission and long-term goal of the California State University, San Bernardino (CSUSB) U-RISE Program
is to increase the diversity of the biomedical research workforce through the mentoring and training of
undergraduate students, especially from underrepresented (UR) groups. The proposed U-RISE program will
accomplish this goal by: 1) providing support to keep UR students in STEM majors, and 2) motivating students
to pursue careers in biomedical research. In order to keep students in STEM majors, we will provide access to
tutors and supplemental instruction for gateway science courses, as well as faculty and peer mentoring. To
enhance motivation to pursue biomedical research careers, students will engage in authentic research
experiences on the CSUSB campus and at research-intensive universities. CSUSB is well positioned to
accomplish the goal of increasing the diversity of the biomedical workforce, because it has a diverse student
body, a strong institutional commitment to student success, and a tradition of faculty mentors who actively
involve undergraduate students in their research.

Public health relevance
Narrative - Relevance The future of the nation's biomedical research workforce depends on the continued development of well-trained undergraduates who seek Ph.D. degrees in the biomedical and behavioral sciences. The next generation of researchers will increasingly be made up of underrepresented students who historically have not pursued such career goals. This project seeks to attract and prepare such students to meet this national need.